Molecular mechanism of MFS and MOP lipid transporters in cell wall biosynthesis.

PROJECT SUMMARY/ABSTRACT
Transporters from the multidrug exporter/oligosaccharidyl-lipid/polysaccharide (MOP) superfamily and
the major facilitator superfamily (MFS) are central to multiple cell wall biopolymer biosynthesis pathways.
Transporters from both superfamilies exhibit significant differences in their architecture, lipid substrate selectivity,
and transport mechanisms. There are several critical gaps in our current understanding of the molecular
mechanism of substrate recognition and transport, substrate specificity, ion-coupling, and activity modulation of
lipid transporters from these two superfamilies. This project seeks to investigate the structure and function of two
lipid transporters involved in teichoic acid synthesis: the glycolipid transporter LtaA from the MFS superfamily
and the teichoic acid transporter TacF from the MOP superfamily. Thus far, my work has revealed the structure
of LtaA in an outward-facing apo state. Additionally, computational methods, cysteine disulfide trapping, and
AlphaFold modelling have been employed to validate inward-facing models of LtaA. Our findings revealed that
in both outward- and inward-facing conformations, this protein displays an amphipathic central cavity crucial for
diglucosyl-diacylglycerol transport, and suggest that LtaA employs a ‘trap-and-flip’ mechanism to facilitate
glycolipid translocation. In contrast, there is currently a lack of structural and functional data regarding the
mechanism of the MOP teichoic acid transporter TacF, and there are still many questions unanswered about the
molecular mechanism of lipid transporters from both superfamilies. We have additionally explored the ion-
coupled lipid transport mechanism of LtaA, recognizing its essential role in modulating the cell wall composition
under acidic conditions. We hypothesize that ion-coupled co-transport of lipids may be linked to adapting the cell
wall composition. However, there are few detailed studies on the precise mechanism of ion-coupling for MFS
and MOP lipid transporters. In this application we want to reveal how LtaA and TacF select for their lipid substrate
at the atomic level, elucidate their ion coupling mechanisms, and reveal the impact of membrane lipids on
transport. Collectively, our proposed research will broadly impact the field of lipid transport by characterizing the
molecular mechanism of transporters from two superfamilies commonly associated to cell wall biopolymer
biosynthesis pathways. These studies have the potential to uncover novel molecular mechanisms underlying
lipid and ion co-transport, which will be critical for understanding the function of cell wall lipid transporters in
bacteria, and will potentially accelerate the structure-based drug design of activity modulators targeting these
proteins.

Public health relevance
PROJECT NARRATIVE Transporters from the multidrug exporter/oligosaccharidyl-lipid/polysaccharide (MOP) superfamily and the major facilitator superfamily (MFS) play central roles in multiple cell wall synthesis pathways. This project aims to study representative MOP and MFS lipid transporters involved in teichoic acid synthesis, elucidating their molecular basis of lipid recognition and transport, and revealing their ion-coupling mechanisms. This research will be critical for understanding the mechanisms of MOP and MFS lipid transporters and their function in cell wall synthesis.